ExPERTS-PC: Engaging Patients in Event ReporTing for Safety in Primary Care

PROJECT SUMMARY/ABSTRACT
Ambulatory adverse drug events (ADEs) occur in 25% of new prescriptions and cause an estimated 4.5 million
office visits and 100,000 hospitalizations per year, with patients from vulnerable populations experiencing
higher rates of ADEs. Patients and caregivers are responsible for medication self-management and observe
ADEs in the home and community, but are not engaged in detecting or reporting ADEs to ambulatory care
teams. The objective of this proposal is to fill this gap by developing a stakeholder-designed tool for patient-
initiated ADE reporting. Aim 1 utilizes natural language processing (NLP) to identify patient, caregiver and
healthcare team contributory causes identified in ADE reports from a multistate Patient Safety Organization.
Aim 2 employs user-centered design to develop and conduct feasibility testing of a prototype text messaging-
based patient-initiated ADE reporting system, working with patients, caregivers and primary care personnel
from the public health safety net, targeting factors identified in Aim 1. This tool will be adapted from an inpatient
text-messaging tool and adapted specifically for low-health literacy primary care patients. Candidate Anjana
Sharma, MD, MAS, is Assistant Professor of Family & Community Medicine at the University of California, San
Francisco (UCSF). She has expertise in mixed methods and observational research studying patient
engagement in quality and safety for vulnerable populations. In this proposal, Dr. Sharma seeks to build skills
in natural language processing, user-centered design for low-health-literacy populations, and intervention
development to enable her to design a patient-initiated ADE reporting tool. Dr. Sharma has assembled a skilled
mentorship team, led by ambulatory patient quality and safety expert Dr. Urmimala Sarkar, including NLP
expert Dr. Atul Butte, user-centered design expert Dr. Courtney Lyles, and primary care leader Dr. Kevin
Grumbach. The career development plan benefits from the extensive resources available at UCSF and
substantial material and methodologic support from the Department of Family & Community Medicine. This
proposal is significant because it expands the limited knowledge base about harms from high-risk medications
occurring in ambulatory care, and develops a novel means to measure ambulatory ADEs through patient-
initiated reports. The work is aligned with Agency for Healthcare Research and Quality's priority areas of
medication safety, ambulatory safety, and patient engagement. Aim 2 focuses on AHRQ priority populations of
urban, low-income and ethnic minority populations. The skills and findings from this proposal will translate into
an R-level proposal for a randomized trial of the patient-initiated ADE reporting tool in a safety-net primary care
network. The proposed career development will advance Dr. Sharma toward her goals of research
independence, expertise in developing interventions that engage patients and family caregivers, and national
leadership in ambulatory care safety and quality for vulnerable populations.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because medication adverse events cause substantial morbidity and cost, yet little is known about how patient and caregivers can participate in monitoring and reporting medication adverse events occurring in the home and community. The proposal will describe outpatient medication adverse events from a previously unexplored Patient Safety Organization database, then develop a text-message-based patient-initiated medication adverse event reporting tool for identifying ambulatory events related to the high-risk medications warfarin, insulin, and opioids. The project is relevant to the priorities of the Agency for Healthcare Research and Quality (AHRQ), including medication safety, ambulatory care safety, patient and caregiver engagement, the role of Patient Safety Organizations, and adverse event reporting.